Claude D. Pepper Older Americans Independence Center (P30 Clinical Trial Optional)

PROJECT SUMMARY OVERALL
This proposal seeks to establish the Claude D Pepper Older Americans Independence Center
at UConn (UConn OAIC) with the overarching goal of developing clinical strategies for
enhancing function and independence in older adults that are more precise, personalized, and
effective. Our focus on Precision Gerontology has emerged through the collective experiences
and insights of our multidisciplinary team of accomplished investigators in the UConn Center on
Aging – all united by a shared commitment to improving the lives of older adults through
research, education, and clinical care.
Our emphasis on Precision Gerontology has been guided by three principles: 1. A growing
heterogeneity or variability over time among individuals involving all aspects of aging that
therefore necessitates a multidisciplinary team-based approach to aging research; 2. Increased
heterogeneity or variability with aging in older adults’ responses to treatment, highlighting the
need for better targeting; and 3. Recognition of a need to incorporate these considerations into
the design and testing of novel geroscience-guided therapies.
These objectives will be achieved by establishing a UConn OAIC through the coordinated
activities of a Leadership and Administration Core (LAC), Recruitment and Community
Engagement Core (RC1), Data Resource Core (RC2), Biomarker and Preclinical Research
Core (RC3), Pilot and Exploratory Studies Core (PESC), and Research Education Component
(REC).
We will seek to address these goals through the following aims:
Aim 1: To develop and refine new approaches to the study and clinical translation of Precision
Gerontology.
Aim 2: To develop and evaluate new research methods, techniques, and collaborative
approaches required to advance the goals of Precision Gerontology.
Aim 3: To identify, develop, and learn from experiences of the next generation of researchers
poised to become leaders in geriatrics research related to the UConn OAIC focus.
Aim 4: To select and support innovative pilot studies that show promise in helping to guide the
design, funding, and completion of more definitive future research studies related to the
UConn OAIC focus.

Public health relevance
PROJECT NARRATIVE OVERALL While aging affects everyone, the manner in which it impacts one’s capacity to remain healthy and independent late in life varies greatly between individuals. Our goal in establishing a Claude D Pepper Older Americans Independence Center at UConn is to learn from such variability and use that knowledge to promote the development of new approaches to the care of older adults that are more precise, more personalized and more effective.